Hormone analysis

The purpose of this contract is to provide support for hormone analysis. These projects focus on using developing and evaluating animal models of disease using hormone analysis as a disease marker.